Vaccinating at Mucosal Surfaces with Nanoparticle Conjugated Antigen and Adjuvant

The incidence of tuberculosis (TB) has increased among the Veterans in recent years because the global burden
of TB is enormous. This burden has escalated with the emergence of multidrug-resistant and extremely drug
resistant Mycobacterium tuberculosis (Mtb) strains and because current vaccines do not elicit long-lasting
protective immunity against TB especially in adults. Hence, the development of new generations of vaccines that
will confer durable protection against TB will significantly improve the quality of life of our Veterans. Our plan
proposes pre-clinical studies that will identify protective CD8+ T cell epitopes and develop mucosal vaccine
delivery platforms for the design of next generation TB vaccines. Mtb enters the host through the respiratory
tract. Hence, optimal protection will require lung-resident CD4+ and CD8+ memory T cells to be positioned at
the frontline to respond immediately to infection. Traditional vaccines and approved adjuvants typically elicit
weak, short-lived T cell responses, and parenteral vaccination is ineffective at installing protective immunity
within tissue mucosae. Moreover, most virus-vectored and subunit TB vaccines employ a small subset of Mtb
antigens, resulting in insufficient epitope diversity for optimal protection, partly because the epitopes that are
presented during Mtb infection and confer protective immunity have not been explored. Hence, our overall
objective is to discover immunogenic Mtb epitopes generated during infection and to incorporate them in an
innovative nanoparticle (NP)-based intranasal vaccine that is designed to promote a balanced pulmonary CD4+
and CD8+ T cell responses that will protect against TB. In preliminary experiments, we have identified 41 novel
peptides from Mtb H37Rv-infected primary macrophages using a proteomics approach. Among these, 17 are
putative HLA-B*07;02-binding epitopes, which we will characterize to advance anti-TB vaccine design. Eliciting
CD8+ T cells that complement a CD4+ T cell response requires that subunit antigens be presented by HLA class
I molecules for CD8+ T cell cross-priming in the context of appropriate inflammatory cues that drive both CD8+
T cell and CD4 differentiation. Our team has recently pioneered a “pathogen-mimicking” vaccine that is based
on pH-responsive, endosome-rupturing NP chemistry. Such NPs promote delivery of antigens and nucleic acid
adjuvant cargoes into the cytooplasm. Preliminary studies demonstrated that a single intranasal administration
of NPs loaded with ovalbumin in conjunction with a structurally optimized 5'ppp-RNA hairpin adjuvant, that
activates cytoplasmic retinoic acid-inducible gene-I, elicits a robust, durable and protective antigen-specific T
cell response in the lungs. Based on these exciting new findings, we hypothesize that intranasal immunization
with NP vaccines co-loaded with naturally processed class I-restricted Mtb-derived epitopes and 5'ppp-RNA
adjuvant will significantly enhance tissue resident CD8+ memory T cell responses in the airways and
parenchyma of the lungs. Our strategy to test this hypothesis is to, (a) evaluate the immunogenicity and
protective potential of naturally processed Mtb epitopes presented by HLA-B*07:02 class I molecules; (b)
determine whether HLA-B*07:02 and B*35:01—two closely-related HLA molecules—present similar epitopes;
and (c) develop a NP vaccine that elicits a durable lung-resident CD8+ and CD4+ memory T cell responses to
Mtb subunit antigen(s) that confers protection against TB. Our multidisciplinary team —consisting of biochemists,
immunologists, microbiologists and bio-engineer— is ideally situated to pursuing the three Specific Aims. We
anticipate that successful completion of the proposed research will yield highly significant knowledge essential
for next generation anti-TB vaccine design. We expect to discover novel protective Mtb epitopes presented and
recognized by multiple HLA molecules. We will also have developed a new delivery platform for mucosal
vaccination that will allow co-delivery of antigens and adjuvants for cytoplasmic immune surveillance. Our
innovative “discover and deliver” approach to vaccine design, will impact clinical practice paradigms against TB
and other intranasal infections and, hence, will better the healthcare of our Veterans.

Public health relevance
Our Veterans are susceptible to infection with Mycobacterium tuberculosis that causes a chronic infectious disease called tuberculosis (TB) that has high morbidity and mortality. This is because the global burden of TB continues to increase with the emergence of multidrug-resistant and extremely drug resistant M tuberculosis strains and the lack of an effective vaccine that protects adults from infection and the ensuing TB disease. The current application seeks support to develop an effective and durable vaccine that can protect our Veterans. As M tuberculosis is transmitted through aerosols and infects the lung mucosa, the challenge is to install immune effector cells at the site of infection. Our team of immunologists, biochemists, bio-engineers and M tuberculosis experts have found ways to install bacteria-specific immune effectors at the site of infection. Using this preliminary information, we will develop and test a durable vaccine against TB in a preclinical model. This work will lead to the design of a clinical vaccine against TB, and, hence, better the quality of lives of our Veterans.